A community-led intervention (DAiLY) promoting a heart-healthy diet and active lifestyle: The Yup'ik way

Project Summary/Abstract
Heart disease is the leading cause of death for Alaska Native men and the second leading cause of death
(after cancer) among women and Alaska Native people overall. The overarching goal of the proposed
multilevel, multicomponent intervention, Diet and Active Lifestyle - Yuuyaraq (DAiLY), is to reduce
consumption of highly processed store-bought foods while promoting intake of subsistence foods, healthy
store-bought foods, and a more active lifestyle to reduce heart disease risk. The Yup'ik word Yuuyaraq means
`the Yup'ik way of life' and encompasses a worldview in which living in harmony with the environment, as well
as sharing of subsistence foods and traditional knowledge is central. The proposed DAiLY intervention is
grounded in the Yup'ik worldview and Indigenous Food Sovereignty, and supported by a foundation of trust
resulting from 22 years of continuous Community Based Participatory Research on heart disease risk and
protective factors with Yup'ik communities. DAiLY is a direct response to the intervention research requests of
community partners and input from Yup'ik Community Research Associates and a Yup'ik Community Planning
Group during the formative research and community engagement process shaping this proposal. The
proposed intervention, based on the Warnecke model of health disparities and social cognitive theory, includes
three components: 1) home-based workshops, framed in the Yupik worldview, led by Community Research
Associates to facilitate interactive discussions with community members about healthy market foods, as well
as the health benefits of locally harvested traditional foods and increased physical activity; 2) local food store
interventions to increase access to, and help build demand for, healthy food options; and 3) traditional
community activities, including Yuraq (Yup'ik traditional dance), Native sports events, and berry festivals, that
provide opportunities to increase physical activity. The three components will be supported and reinforced via
community media, including Facebook, text messaging and visual materials. A continuous metabolic
syndrome score will be used as the primary outcome to assess changes in heart disease risk, and objective
stable isotope biomarkers of diet and a validated food frequency questionnaire will be used to measure intake
of traditional and market foods. We will test the DAiLY intervention in four Yupik communities, randomized to
immediate and delayed intervention. Aim 1, will determine the effectiveness of the DAiLY intervention on heart
disease risk by measuring change in a continuous metabolic syndrome risk score (primary outcome). Aim 2,
will assess implementation of the DAiLY intervention using a mixed methods process evaluation to determine
fidelity, dose, and reach, as well as barriers and facilitators to implementation of program activities and
participant satisfaction and engagement. Aim 3, will determine the impact of the DAiLY intervention on
community-level outcomes, including access to, and sales of, healthy foods in local stores, as well as
opportunities for physical activity at community venues.

Public health relevance
Project Narrative Heart disease is the leading cause of mortality among Yup'ik men and the second most common cause of death among Yup'ik women. This study will design and evaluate a culturally grounded, multi-level intervention focused on increasing intake of traditional foods and healthy market foods, decreasing intake of processed foods and increasing physical activity to reduce heart disease risk among Yupik adults. If successful, the intervention can be disseminated to other Yup'ik communities.